BIOCHEMICAL ROLES OF SELENIUM IN SELENOPROTEINS AND SELENO-TRNAS

The selenium-dependent clostridial glycine reductase that synthesizes ATP concomitant with the reductive deamination of glycine was investigated with emphasis on (1) large-scale isolation of the essential enzyme components to be used for reaction mechanism studies and (2) mechanism of biosynthesis of the selenoprotein component (protein A) of the reductase complex. A reproducible protocol for the isolation of protein C in apparently homogenous form was developed using hydrophobic chromatographic procedures. The resulting material, enriched about 1000-fold, is exceedingly stable and can be stored many months at -20 degrees C with no detectable loss of activity. The mechanism of insertion of a selenocysteine residue into selenium-dependent enzymes also was studied in a collaborative project with August Bock's group in Munchen using a formate dehydrogenase in Escherichia coli as experimental material. This very oxygen-labile enzyme, which had not previously been isolated, was purified extensively using the NIH anaerobic laboratory. The membrane-bound enzyme was solubilized and enriched using hydrophobic chromatographic procedures. After many difficulties we finally have devised a procedure for isolation of a selenocysteine peptide from the purified selenium- containing formate dehydrogenase for sequence analysis. The gene encoding this protein contains a TGA stop codon which is the presumed codon specifying insertion of the selenocysteine residue but this has to be proven by amino acid sequence of the gene product. Site specific mutagenesis of the TGA codon to TGC (cysteine codons) by Bock's group eliminated the selenium requirement for formate dehydrogenase expression. The resulting enzymes in which cysteine replaced selenocysteine exhibited some catalytic activity. The cysteine-containing enzyme was partially purified using the same procedures developed for isolation of the selenocysteine-containing species. Precise comparison of catalytic activities of Se vs. S enzyme species will be made when highly purified samples are obtained. Replacement of selenocysteine with serine resulted in a completely inactive enzyme.